PIGMENT DISPERSION WITH AND WITHOUT GLAUCOMA

The purpose of this project is to determine the risks of patients with pigment dispersion syndrome to developing glaucoma. Comparisons of patients with and without glaucoma will be made on the basis of diagnostic tests, genetic screening, aqueous humor dynamics, and pupillary responses to light. The data acquired may enable a determination of the risk of patients with pigment dispersion syndrome to developing glaucoma, as well as adding to the understanding of the pathology of the disease.